Health risks and disparities in services for pregnant individuals

PROJECT SUMMARY
Crisis pregnancy centers (CPCs) are non-profit organizations with the mission of supporting pregnant people in
not having an abortion. To this end, CPCs offer pregnant people free services (e.g., urine pregnancy tests,
non-diagnostic ultrasounds, and peer counseling on a limited range of pregnancy options) and the opportunity
to earn infant-related material items by attending classes. Public funding increasingly plays an important role in
the functioning of CPCs. In Ohio, state funding of CPCs increased from $1 million to $7.5 million in 2019.
Despite advertising the provision of health procedures and receiving state funding and endorsement, CPCs
typically do not employ medical staff and are not licensed as medical facilities. According to a recent U.S.
Supreme Court case, CPCs are not compelled to disclose that they are not medical facilities. Professional
medical organizations warn of possible health risks of CPCs; however, to date, little research has been
conducted on their possible effects. We conducted two preliminary studies in preparation for this project. First,
in our population-based survey of adult, reproductive-age women in Ohio, we found that attending a CPC is
common, with 14% of women reporting ever CPC attendance. Attendance was more common among those
who reported being non-Hispanic Black and of low socioeconomic status. Second, in a study in which we
conducted in-depth interviews with CPC staff and clients, we found that clients often attend the CPC for
pregnancy confirmation and some perceived the CPC to be a medical clinic that provides early pregnancy
care. This project seeks to quantify health-related outcomes associated with attending a CPC and, among
those attending a CPC, disparities in services received. Specifically, we will use survey data to address two
aims: 1) To assess whether delayed entry into prenatal care is more common among people who had
previously attended a CPC for the current pregnancy relative to non-attendees; and 2) To assess
whether the pregnancy options counseling provided at CPCs differs by client demographics (e.g.,
race/ethnicity, marital status, and religion) after controlling for client pregnancy plans before the CPC
visit. To address the aims, we will survey 400 patients who recently entered into prenatal care. The sample will
include 200 women who had attended a CPC before entering into prenatal care and a comparison group of
200 women who had not attended a CPC before entering into prenatal care. We will use frequency matching
for enrollment (age and race/ethnicity) and matching with propensity scores during the analysis to reduce bias.
While the literature on CPCs has been expanding in recent years, almost no quantitative data has been
published on CPC clients. We expect the study will yield fundamental evidence on the possible consequences
of CPC attendance among pregnant people.

Public health relevance
PROJECT NARRATIVE Crisis pregnancy centers (CPCs) increasingly are supported with public funding and are endorsed by the state as referral sites for family planning and care. Despite this, CPCs typically are not licensed as medical facilities. We propose to conduct a survey of prenatal care patients who attended – and a comparison group of those who did not attend – a CPC before initiating prenatal care to understand the possible risks associated with CPCs.